Development of an Optimized Adjuvanted TB Vaccine

Vaccine Adjuvant Discovery Program: To develop a lead, optimized adjuvanted tuberculosis (TB) vaccine for IM or IN administration using specified adjuvants in combination with recombinant or circRNA TB antigens within the context
of a vaccine to prevent TB.